Supernumerary Centrosomes and Cell Proliferation

PROJECT SUMMARY
The centriole is a conserved organelle of metazoans that is found at the core of microtubule
organizing centers, centrosomes, and at the base of cilia and flagellae. Centriole dysfunction leads to a
wide range of diseases including the developmental defects of ciliopathies; defective brain development
in microcephaly; and in cancer where supernumerary or defective centrosomes are associated with
poor prognosis. Centriole duplication is promoted by Plk4, which phosphorylates cartwheel proteins to
mediate their assembly. We and others have found that induction of Plk4-mediated centriole
amplification results in hyperplasia of several tissues and increases the susceptibility to tumorigenesis
in the mouse in the absence of the p53 tumor suppressor.
Both the loss and acquisition of extra centrosomes normally block cell proliferation. However, the
pathway that responds to loss of centrosomes differs from several pathways that respond to
supernumerary centrosomes. Therefore, to identify proteins that signal or respond to the presence of
extra centrosomes, we carried out a genome-wide screen for genes that when deleted or knocked-
down permit the proliferation of cells that have elevated levels of Plk4. This has identified new
pathways whereby cells respond to supernumerary centrosomes: a previously unknown involvement of
specific Rac-mediated signaling that regulates centriole duplication; proteins that regulate the
elongation, disengagement and separation of centrioles; and negative regulators of ciliogenesis.
Here we follow three approaches to understand how centriole number is regulated in proliferating
cells. First, we will determine how the Arh15gap GTPase Activating Protein acts upon the Pak1/2
protein kinases to regulate Plk4 levels or activity and upon Arp2/3 to regulate spindle associated actin
to permit an increase in centriole- and cell-cycle arrest. Second, we examine how known components
of the centriole affect the execution of the centriole and cell cycles at unexpected points. We will
determine how the Usp33 deubiquitinase regulates the centriole capping protein complex to protect the
nascent procentriole and how proteins required in the centriole cycle for both centriole disengagement
and centrosome separation contribute to the block to cell proliferation in the presence of supernumerary
centrosomes. Finally, we will explore how negative regulators of ciliogenesis block primary cilium
formation in the presence of extra centrioles in such a way as to arrest cell proliferation.
We anticipate that this research will advance our understanding of the multiple ways in which cells
respond to supernumerary centrosomes. It will identify pathways that can be targeted for restoring
centriole numbers or cell cycle regulation in tumor cells or for targeting such cells for apoptosis. This
will find translational application in developing multiple drug strategies for cancer treatment.

Public health relevance
PROJECT NARRATIVE Centrioles are core components of centrosomes, which organise the dynamic microtubule cytoskeleton, and primary cilia, which enable many signalling pathways. Plk4-mediated centriole amplification results in tissue hyperplasia and increased susceptibility to tumorigenesis in the mouse providing a model for the supernumerary or defective centrosomes found in a high proportion of human tumors. This research will advance our understanding of cellular responses to supernumerary centrosomes and identify pathways that can be targeted for restoring centriole numbers or cell cycle regulation or for directing such cells to cell death, thereby finding translational application in the development of multiple drug strategies for cancer treatment.